Master Level Learning

Regarding the mastery learning project for mechanical ventilation in incoming Critical Care fellows, we have collected survey and test data from the summer of 2016, winter 2017, and spring 2017 in one group of incoming fellows (N=36). We have also started collecting data from a second set of incoming fellows with survey and test data from the summer of 2017 (N=36). Our next step is to perform a statistical analysis (by paired t-test) to determine whether the education program improves test performance and whether decay of knowledge occurs between summer and winter testing as well as winter and spring testing. Regarding the mastery learning project for bronchoscopy in incoming Critical Care fellows, we have collected survey and test data from the summer of 2016, winter 2017, and spring 2017 in one group of incoming fellows (N=16 ). We have also started collecting data from a second set of incoming fellows with survey and test data from the summer of 2017 (N=16). Our next step is to perform a statistical analysis (by paired t-test) to determine whether the education program improves test performance and whether decay of knowledge occurs between summer and winter testing as well as winter and spring testing. Regarding the mastery learning project for mechanical ventilation in respiratory therapists, we have collected survey and test data from June 2017 (N=15). We will repeat the survey and testing with the same group of therapists and will collect this data from January 2018. Our next step is to perform a statistical analysis (by paired t-test) to determine whether the 2 days of Boot Camp education improves test performance and subjective comfort with interpretation of ventilator waveforms.